IS HELIUM A BETTER GAS FOR LAPAROSCOPIC SURGERY THAN CARBON DIOXIDE?

LAB USE ONLY: To determine which gas is better for insufflation in laparoscopic surgery. Urinary cortisol and plasma catecholamine levels will be used to evaluate the stress response to helium or carbon dioxide during laparoscopy.